Core 2: Pathology Core

SUMMARY/ABSTRACT
The objective of the Pathology Core (Core 2) is to serve as a centralized infrastructure to provide the materials
and technical expertise necessary to accomplish the translational studies proposed by the Emory University
Lung Cancer SPORE Research Projects and Developmental Research and Career Enhancement programs.
With experience and expertise specifically in lung cancer pathology, the Core will interact directly with each
SPORE project, the Administrative and Biostatistics and Biomedical Informatics Cores, to ensure efficient and
highly-coordinated procurement, archiving, and storage of both fresh and archived lung cancer tissue specimens.
Continuous communication between clinicians, scientists, research nurses, biostatisticians and pathologists,
together with established standardized operating procedures for all core activities, will provide optimal tissue
collection and accurate processing, analysis and storage of each sample. The Core will function as the main
repository of patient specimens. This Core will utilize and expand the well-established tissue banking efforts at
the Winship Cancer Institute of Emory University for translational research, including annotating human tissue
samples with relevant clinical and pathologic data that is collected and stored from the patient history, and
maintaining patient confidentiality. Histopathologic analysis by the core pathologist will confirm the quality of
study tissue in research specimens. Selected cellular biomarkers utilizing immunohistochemistry (IHC) will be
interpreted by the core pathologist. In addition, animal study specimen processing, histopathology, IHC, and
pathologic interpretive support will be provided. Collectively, the primary functions of the Core are stated in the
following aims: 1) Comprehensively acquire, process, store, catalog and disburse tissues, cells and blood with
relevant clinico-pathologic data; 2) Provide pathologic and molecular genetic classification of lung tumors and
interpretation of immunohistochemical stain results; 3) Facilitate human tissue-based investigation of the SPORE
research projects; 4) Support Administrative Core-initiated intra-SPORE collaborations, inter-SPORE
collaborations, and collaboration between investigators at our own and other institutions including other peer-
reviewed projects funded by NCI/NIH and other agencies using SPORE-generated tissues.

Public health relevance
PROJECT NARRATIVE The SPORE Pathology Core will provide expertise in lung cancer pathology to ensure efficient and highly- coordinated procurement, archiving, and storage of both fresh and archived lung cancer tissue specimens to support the Emory University Lung Cancer SPORE projects. These efforts will further advance our understanding of the biology of lung cancer, and will help define novel strategies for the treatment of lung cancer.